Machine Learning Based Differential Mobility Spectrometry Library Development

Project Summary
The goal of the project proposed is to develop a gas chromatography and differential mobility spectrometry
(GC/DMS) molecular identification library for volatile organic compounds (VOCs) using a deep neural network
approach. Vox Biomedical scientists will test the hypothesis that a novel, multi-task neural network architecture
can predict characteristics of an previously unseen analyte from its GC/DMS spectrum.
Vox Biomedical is in the process of commercializing the GC/DMS based microAnalyzer instrument, developed
at DRAPER, for detecting the presence of psychoactive drugs and disease through exhaled breath analysis.
While drug detection consists of measuring the concentrations in the exhaled breath of compounds whose
identity is well known (such as psychoactive opioids and cannabinoids), exhaled breath disease detection is
focused on characterization of a particular disease’s exhaled volatile organic compound signature. Volatile
organic compounds (VOCs) are byproducts of cellular metabolism that travel from cells throughout the body to
the lungs, where they are efficiently exhaled in the breath. VOCs have become of interest as biomarkers of
metabolic diseases such as cancer, kidney disease and diabetes. The current generation of exhaled breath VOC
based disease detection methods rely on gas chromatography and mass spectrometry (GC/MS), which, while
highly sensitive, is a complex analytical modality that is expensive, slow, and must be operated by skilled
professionals.
The microAnalyzer instrument’s inherent portability, ease of use, and ability to obtain results at the point-of-
measurements make it an ideal instrument for breath-based disease detection. However, the currently a
GC/DMS peak can only be identified through characterization of a chemical standard or by performing
confirmatory GC/MS analysis using a similar sample. This makes biomarker discovery a resource and time
intensive process. The creation of a VOC chemical identity library, as would result from successful completion
of the proposed project, will allow the identity of samples introduced to the microAnalyzer instrument to be
predicted without the need for confirmatory standard characterization or GC/MS work. This will make biomarker
discovery for disease a less resource intensive process expediting the discovery and confirmation of biomarkers
for early-stage disease detection, ultimately saving lives.

Public health relevance
Project Narrative This project is focused on creating a molecular identification library that can be used with fieldable instruments for exhaled breath analysis. The proposed work will enable the constituents of an exhaled breath sample to be identified without referencing a standard. Such capabilities will enable breath-based biomarker discovery for diseases such as cancer, liver disease, and invasive infection.